Capacity for CARB WGS Surveillance at Cornell AHDC

Project Summary/Abstract
There is a growing need for monitoring antimicrobial resistance in animals in order to protect the safety of
people and animals. Capacity for accredited bacterial whole genome sequencing in veterinary diagnostic labs
supports the mission of FDA to ensure the safety of our nation's food supply and protect public health by
enabling real-time monitoring of isolates. In this proposal, we request funding to maintain capacity for our
accredited bacterial sequencing services for FDA. The capacity to perform advanced molecular
characterization of bacterial isolates in a reliable manner is critical to our ability to respond quickly to suspected
microbiological contamination and monitor antimicrobial resistance in animals and feed. Importantly, having
this capacity in veterinary diagnostic laboratories fills a critical surveillance gap by monitoring live animals for
antimicrobial resistance. In addition to serving as one of the sequence reference labs, the Goodman laboratory
at Cornell has provided analytic support to the program office and mentorship to the other laboratories by
providing validation, methods, and Quality Assurance documentation for these procedures in support of
ISO:17025 accreditation. The proposed studies will have important impacts for both human and animal health
and will improve the capabilities of Vet-LIRN to perform effective surveillance for food-borne pathogens.

Public health relevance
Project Narrative Accredited testing for antimicrobial resistance in veterinary diagnostic laboratories is needed to support the mission of FDA to protect public health. In 2017, FDA Vet-LIRN launched an active surveillance initiative including whole genome sequencing as a key component for mitigating the lack of standardization in antibiotic susceptibility testing in their network. Sequencing methods are now standardized across five laboratories in the network, including Cornell, and we are requesting support for these activities for the next five years.